Age-dependent effects on microglia-mediated control of neuronal activity

Project Summary/Abstract
This proposal addresses a novel microglia-controlled neuronal activity feedback mechanism and its potential
contribution to aging-dependent neuropathology. Aging in mice and humans is associated with alterations to
neuronal circuit excitability and function, increased seizure susceptibility, and neurodegeneration. Our recent
studies have identified microglia as novel regulators of neuronal activity and function, maintaining homeostatic
levels of neuronal activation, thereby serving as brake pads for hyperexcitation. Preliminary evidence suggests
this neuroprotective function may be altered in aging, potentially as a consequence of inflammatory microglia
activation associated with aging and neurodegenerative disease. I hypothesize that microglia play a critical role
in aberrant neuronal responses and dysfunction in the aging brain. In support of this idea, we found that microglia
are able to regulate neuronal activity in an activity dependent manner by responding to ATP released during
neuronal activation and metabolizing it into adenosine, thereby suppressing neuronal activity. We further found
that age-associated increase in pro-inflammatory gene expression in microglia is associated with changes in this
mechanism. To investigate my hypothesis, I will first elucidate the exact mechanisms of microglia-mediated
neurosuppression, using the healthy adult striatum as a model. Microglia express the rate-limiting enzyme, CD39,
which controls ATP to AMP degradation, while AMP to adenosine degradation is accomplished by CD73, which
is expressed in microglia but also by striatal D2 medium spiny neurons. This suggests that microglia may either
be independently sufficient to produce adenosine by expressing both CD39 and CD73, or this mechanism
requires microglia-neuron interactions. To investigate this, we propose to generate transgenic mouse models to
identify the relative contributions of CD73 found on microglia versus D2 medium spiny neurons. Microglial
sufficiency of adenosine production may implicate this as a brain-wide mechanism of neuroprotection against
aberrant neuronal activation. Additionally, to investigate the presynaptic and postsynaptic specificity of this
microglial mechanism, we will use transgenic mouse models lacking adenosine receptor either on projection
neurons or D1 medium spiny neurons. Prevention of adenosine-based neuronal activity inhibition on either the
presynapse or postsynapse will recapitulate the effects seen with loss of microglial adenosine generation. Using
these models, we will assess neuronal activation by immediate early gene expression, open field locomotor
activity, and seizure susceptibility. We further demonstrated that expression of key genes involved in microglia
driven neuronal activity modulation are downregulated in aged animals. However, this has yet to be specifically
observed in microglia. Therefore, we proposed to perform gene expression analysis specifically in microglia of
different brain regions and animals of different ages. This information is critical to our understanding of the cellular
mechanisms by which microglia regulate neuronal function and may help to identify key regulators of this
pathway, leading to the development of novel approaches for the treatment of age-associated disorders.

Public health relevance
Project Narrative Alterations in neuronal and glia activity during ageing have been associated with cognitive decline, seizures, neurodegeneration, and other age-related neuropathology. We found that microglia, the resident macrophages of the brain, play a critical role in protecting the brain from aberrant neuronal activation via a novel adenosine- dependent mechanism that appears to be attenuated in the aging brain. In this proposal we will address the mechanism of microglia-controlled neuronal activity regulation and its potential contribution to age-dependent alterations by integrating highly specific genetic and molecular approaches with assessment of mouse behavior.